Regulation of lipogenesis by TCA cycle metabolism

Project Summary:
Lipogenesis is essential for normal physiology and its dysregulation is a notable feature of obesity, diabetes,
cardiovascular disease, cancer, neurodegeneration and infection. Classical regulation of de novo
lipogenesis involves transcriptional regulation of lipogenic gene expression via hormone mediated SREBP
activation, and/or carbohydrate sensing via ChREBP activation. However, neither program facilitates
substrate handling nor set the cellular energy status amenable to lipogenic conditions. The mitochondria,
specifically the TCA cycle, is the putative source of acetyl-CoA used for lipid synthesis but before transport
to the cytosol, it is converted to citrate, a step that consumes TCA cycle intermediates. The balance
between TCA cycle cataplerosis (loss of TCA cycle intermediates) and anaplerosis (replenishment of TCA
cycle intermediates) and may help to determine the rate at which citrate can be used for lipid synthesis.
These pathways are known to be disrupted in many diseases, that also have pathological lipid metabolism.
Thus, we will examine how anaplerotic and cataplerotic pathways of the TCA cycle help to mediate the
appropriate lipogenic response to nutrition, by promoting substrate (e.g. citrate) availability and/or cellular
energy status necessary for lipogenic reactions. We will use state of the art stable isotope tracers, analytical
chemistry platforms and mouse genetics to evaluate the role of these pathways in controlling rates of lipid
synthesis. Completion of this project will identify new metabolic mechanisms for the regulation of lipid
synthesis that complement transcriptional mechanisms and may have particular relevance to the growing
list of diseases known to disrupt TCA cycle metabolism.

Public health relevance
Project Narrative: The synthesis of lipids in our bodies is essential for normal metabolism but is abnormal in diseases like obesity, diabetes, cardiovascular disease, cancer, neurodegeneration and infection. Mitochondria are subcellular organisms known for oxidizing lipids, but they also have a less understood role in synthesizing lipids. This project investigates how mitochondria contribute lipid synthesis, with the goal of better understanding how disease disrupts the normal regulation of lipid metabolism.